Epigenetic regulation of Cdk5 in cognition and emotion

PROJECT SUMMARY
Negative valence states can be modeled in mice using fear conditioning and reward seeking (an example of
frustrative nonreward). Such states lead to transcriptional aberrations at the level of both individual genes and
genome-wide; these changes are also sexually dimorphic. One gene of considerable interest is cyclin-dependent
kinase 5 (Cdk5). While most prior studies have focused on the mechanisms of Cdk5 protein activation and
signaling in stress-evoked behavior, we recently reported that cocaine exposure and fear conditioning lead to
transcriptional regulation of Cdk5 in male mouse brain. This proposal will directly examine the connection
between Cdk5 gene activation and Cdk5 protein activity.
Furthermore, there is emerging evidence that Cdk5-associated histone modifications correlate with drug-, and
fear-induced Cdk5 expression. The current proposal explores the functional relevance of stress-induced histone
modifications at the murine Cdk5 locus across multiple behavioral paradigms using the innovative approach of
locus-specific epigenetic editing. This approach allows us to recapitulate endogenous mechanisms of gene
expression, avoiding non-physiologically relevant changes in protein expression resulting from traditional
knockout or overexpression. Furthermore, we apply cell-type specific analyses to elucidate Cdk5 function in
brain regions across the corticostriatal-limbic circuitry in the regulation of negative valence states. This proposal
will examine the direct functional relevance of sex-specific, epigenetic regulation of Cdk5 by fear conditioning
(Aim 1) and cocaine seeking during abstinence (Aim 2) using targeted epigenetic editing. Sex- and region-
specific phosphoproteomic profiling will be applied to define relevant Cdk5 targets. Identification of the precise
transcriptional and epigenetic mechanisms by which stress regulates specific gene expression is critical for the
development of targeted antidepressant treatments.

Public health relevance
PROJECT NARRATIVE Cdk5 is a brain expressed serine/threonine kinase known to regulate negative valence states in male rodents, yet very little is known about the role of Cdk5 in female brain or regulation of the Cdk5 gene in either sex. Gene expression changes conferred by molecular alterations to the genome, known as epigenetic modifications, underlie affective states, including reward seeking and fear learning and memory. There is growing evidence that these changes, and the physiological responses to stress, are regulated differently in men and women. This proposal specifically manipulates Cdk5 in order to pinpoint the role of epigenetic regulation of this single gene following different types of stress. The experimental strategy will complement 30 years of existing literature on the role of Cdk5 in male brain.